The role for ER associated degradation (ERAD) in T cell homeostasis and memory

PROJECT SUMMARY
CD8+ T cells are critical to eradicate viral infections and tumors, as well as providing
long-lasting protection; however, not all immune responses elicit functional and durable immune
responses leading to loss of protection against intracellular pathogens and cancer. Effective T
cell immunity requires tight control to maintain the appropriate equilibrium between cellular
quiescence, activation and cell death. Elegant work has been done to elucidate the
transcriptional, epigenetic and metabolic networks that regulate T cells. In contrast, much less is
known about how cellular protein homeostasis (proteostasis) regulates CD8+ T cell fate.
Proteostasis is maintained primarily through the endoplasmic reticulum associated degradation
(ERAD) and unfolded protein response (UPR) pathways. ERAD complexes recognize misfolded
proteins in ER and translocate them into the cytosol for proteasomal degradation. Sel1L is a
critical component of the ERAD complex, facilitating the recognition, retro-translocation and
subsequent proteasomal degradation of misfolded proteins in the ER. Though the role of the
UPR has been studied in T cell responses, nothing is known how Sel1L/ERAD controls CD8+ T
cell fate. Using conditional deletion of Se1lL in murine T cells to disrupt ERAD, we recently
identified a novel role for ERAD in T cell quiescence and survival at steady-state. In additional
preliminary results, we demonstrate that antigen-specific CD8+ T cells experience dynamic ER
stress during acute viral infection and Sel1L is required to protect antigen-specific CD8+ T cells
in a cell-intrinsic manner from cell death following viral infection. Our long-term goal is to identify
molecular mechanisms that regulate T cell fates and discover novel therapeutic targets that can
be used to modulate human T cell responses against infections and tumors. The objective of
this proposal is to dissect how Sel1L/ERAD regulates CD8+ T cell fate at steady-state and
following infection. Our central hypothesis is that Sel1L/ERAD is required to maintain cellular
proteostasis in CD8+ T cells during homeostasis and following antigen activation. To test our
central hypothesis, we will pursue the following aims: 1) to determine how Sel1L/ERAD
regulates CD8+ T cell homeostasis and 2) to dissect the mechanisms by which Sel1L/ERAD
preserves CD8+ T cells following antigen activation. In this proposal, we will identify how
Sel1L/ERAD protects naïve and activated CD8+ T cells against dysregulated proteostasis,
inappropriate UPR activation and altered cellular metabolism. The completion of these aims will
lead to knowledge that has the potential for offering new therapeutic targets that can enhance T
cell responses to viral infections and improve protective vaccines responses.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it focuses on identifying a novel pathway that regulates CD8+ T cells, which are critical immune cells that provide protection and long-term immunity against viral infections. This proposal will define how maintenance of appropriate protein quality control regulates CD8+ T cells at homeostasis and following viral infection. An understanding of pathways that regulate CD8+ T cell immunity will provide mechanistic insights to guide design of therapeutic strategies to enhance protective T cell responses, such as following infectious diseases or vaccination.